Elucidating the molecular mechanism of Daple- FLT3 and Daple-PDGFRB gene fusion in blood cancers

Project Summary/Abstract
Not Applicable.
This is an application for Administrative Supplement, per Notice Number: NOT-GM-22-017
[Notice of Special Interest (NOSI): Administrative Supplements for Equipment Purchases for
Select NIGMS-Funded Awards]. Per PA-20-272, forms must be completed for the
supplemental activities only and must not reflect funding or activities for the previously
awarded parent award.
There is no change from information submitted and approved for the existing awarded
Parent Grant 1R16GM146720-01.

Public health relevance
Project Narrative Not Applicable. This is an application for Administrative Supplement, per Notice Number: NOT-GM-22-017 [Notice of Special Interest (NOSI): Administrative Supplements for Equipment Purchases for Select NIGMS-Funded Awards]. Per PA-20-272, forms must be completed for the supplemental activities only and must not reflect funding or activities for the previously awarded parent award. There is no change from information submitted and approved for the existing awarded Parent Grant 1R16GM146720-01.